Optimization and Characterization of "MYC Degraders" for Pediatric Medulloblastoma

PROJECT SUMMARY
Medulloblastoma (MB) is a highly malignant tumor of the cerebellum that occurs most frequently in children.
Despite advances in treatment – including surgery, radiation, and chemotherapy – approximately one-third of
MB patients still die from the disease and survivors suffer severe side effects as a result of treatment. Genomic
profiling and bioinformatic analyses of patient samples have identified four subgroups of MB – WNT, Sonic
hedgehog (SHH), Group 3 (MYC-driven) and Group 4. These subgroups differ in terms of mutations, gene
expression profiles and patient outcomes, and patients can be stratified using relevant genetic and
immunohistochemical markers. Approximately one-quarter of MBs are Group 3 (G3) tumors, which exhibit
overexpression or amplification of the c-Myc (MYC) oncogene. Patients with G3 MB are more likely to present
with metastatic disease at time of diagnosis, have a higher incidence of recurrence and the poorest survival rate.
Thus, more effective therapies for G3 MB are critically needed.
To identify MYC inhibitors that would be effective in G3 MB, we developed a phenotypic, target-agnostic assay
using disease-relevant cells isolated from G3 MB orthotopic patient-derived xenografts (PDXs). The assay was
designed to identify small molecules that reduce endogenous MYC levels – the signature molecular marker of
G3 MB – in 4 hours, to preferentially modulate targets directly affecting MYC stability and avoid indirect or off-
target effects at later time points. We applied this assay to screen a 100,000 compound collection and identified
small molecule scaffolds that robustly decrease cellular MYC levels. Hits were validated in a rigorous testing
funnel designed to avoid undesired mechanisms of action, and initial SAR was explored for several scaffolds.
From these studies the most promising series was prioritized with activities in the 100 nM potency range as well
as compound properties indicative of good BBB penetration. We further confirmed that the compounds in this
series decrease cell viability after 48 hours exposure and that this effect correlates with potency in the MYC
assay. Preliminary data for the most active compound of this series, SBI1242, indicate that this decrease in cell
viability of G3 MB patient cells is selective over iPSC-derived neurons, suggesting a possible therapeutic window.
The goal of this proposal is to further optimize SBI1242 for preclinical in vivo testing and use the best analog to
test our hypothesis that inhibitors of the G3 MB signature biomarker MYC identified in a highly disease-relevant
context can safely and effectively arrest or reverse tumor growth in our G3 MB-specific orthotopic PDX mouse
model. We anticipate that successful completion of these studies will be a significant step towards our long-term
goal of identifying novel, safe, and effective treatments for MB and other MYC-driven cancers.

Public health relevance
PROJECT NARRATIVE Medulloblastoma (MB) is a highly aggressive pediatric brain tumor; the most lethal form of the disease – called Group 3 MB – is characterized by high levels of the cancer-causing protein MYC. Using cells from Group 3 MB patients, we have identified compounds that can degrade MYC, and thereby eliminate a key driver of tumor growth. We hypothesize that these compounds can be developed into more effective and less toxic therapies for patients with this devastating disease.